Role of Sedation in the Post-Cardiac Arrest Neurological Recovery

Sudden cardiac arrest (CA) is a leading cause of death. Despite advances in cardiopulmonary resuscitation
(CPR) methods, only 10-20% of adult CA victims survive to hospital discharge. Neurologic injury is the main
cause of death and reason to withdraw care in patients who initially achieve return of spontaneous circulation
(ROSC) after CA. Although mild hypothermia has been widely adopted to improve neurologic recovery after
ROSC, recent evidence refuted its efficacy leading to a new guideline that does not recommend hypothermia
any longer. Because majority of comatose post-CA patients are sedated regardless of temperature management,
precise impact of sedation on post-CA neurologic recovery is unknown. Studies excluding post-CA patients
suggest that sedation provides very poor sleep quality, leading to a significant push to minimize sedation in ICU.
On the other hand, post-CA sedation may exert neuroprotective effects. Cerebrovascular dysregulation is a
common feature of post-CA encephalopathy and associated with poor outcomes. Sedation may normalize
cerebral metabolism by concurrently modulating energy demand and cerebral blood flow (CBF) after CA. Further
studies are needed to elucidate the role of sedation on neurologic recovery after CA. Quantitative
electroencephalogram (EEG) is widely used for post-CA neuroprognostication. Recent studies showed that
induction of slow-wave activities on EEG by propofol early after ROSC is associated with favorable neurologic
outcomes in post-CA patients. Anesthesia-activated neurons (AANs) in hypothalamus are activated by diverse
classes of anesthetic agents to produce slow-delta oscillations. However, physiological role of slow-wave
oscillation, especially in post-ischemic brain, is unknown. In recently published studies related to this proposal,
we evaluated the effects of sedation on outcomes after CA in hypothermia (33°C)-treated mice. We observed
that, compared to hypothermia without sedation after CA, hypothermia with sedation with an intravenous infusion
of propofol or dexmedetomidine (DEX) attenuated cerebral hyperemia, induced higher slow wave EEG power
after ROSC, and improved neurological outcomes and survival in male and female mice. In new preliminary
studies, post-CA sedation with ketamine infusion failed to improve survival, whereas chemogenetic activation of
AANs after ROSC induced slow wave sleep and tended to improve survival rates in mice. Based on these results,
we hypothesize that post-CA sedation during hypothermia improves neurological recovery after CA by promoting
electrophysiological recovery and preventing dysregulation of cerebrovascular function and metabolism. To
address this hypothesis, specifically, we propose to determine the effects of post-CA sedation with propofol or
dexmedetomidine during normothermia, to characterize the effects of post-CA sedation with ketamine on
neurologic outcomes, and to elucidate the role of slow-wave oscillation in the neuroprotective effects of post-CA
sedation. While most post-CA patients are sedated, how sedation alters neurologic outcomes remains largely
unknown. The proposed studies will fill the knowledge gap and seek to optimize sedation in post-CA care.

Public health relevance
Majority of patients who are resuscitated from sudden cardiac arrest have poor neurological outcomes. Although virtually all comatose post-cardiac arrest patients are sedated after successful cardiopulmonary resuscitation, the effects of sedation on the brain function of post-arrest patients are unknown. This study will seek to elucidate the effects of post-cardiac arrest sedation on recovery of brain function using advanced electrophysiological and genetic tools in male and female mice subjected to experimental cardiac arrest.